4-hydroxymandelate for HPDL deficiency, a novel mitochondrial encephalopathy

Abstract
HPDL encodes the mitochondrial enzyme 4-hydroxyphenylpyruvate dioxygenase-like, which converts the
tyrosine metabolite 4-HPPA to 4-hydroxymandelate (4-HMA). HPDL biallelic mutations lead to a mitochondrial
encephalopathy (ME) syndrome with two distinct presentations: neurodevelopmental disorder with progressive
spasticity and brain white matter abnormalities (NEDSWMA, MIM619026) and Autosomal Recessive Spastic
Paraplegia 83 (SPG83, MIM619027). Genotype analysis suggests that truncating mutations correlate with
NEDSWMA, while missense mutations correlate with SPG83. Preclinical mouse models show that 4-HMA is a
critical precursor for the mitochondrial coenzyme Q10 cofactor involved in the electron transport chain. Ina
mouse Hpdl knockout model, 4-HMA supplementation prevented and ameliorated ME features and death,
suggesting that HPDL-deficiency syndromes (HDS) may be a treatable mitochondrial disease.
This application lays the groundwork for a clinical trial to assess the benefit of 4-HMA or a derivative to
treat NEDSWMA and SPG83. We identified over 200 patients with HDS worldwide, and 40 patients in the
United States. We have an active patient registry to prepare for a future interventional clinical trial using 4-HMA
supplementation in HDS patients. For this proposal, we plan to enroll 10 patients with the NEDSWMA
phenotype in a natural history study. We have found that 4-HMA is a measurable biomarker and can be readily
measured from blood samples. Here we propose to leverage our existing patient registry by testing 4-HMA and
urine organic acids as biomarkers of disease status (Aim 1) and conducting an 18 month natural history (Aims
2 and 3). The result of this work may provide a strong preclinical proof of concept IND-enabling dataset, blood
and urine biomarkers, and fit-for-purpose outcome measures to support a subsequent single-site clinical trial.

Public health relevance
Project Narrative HPDL deficiency syndrome is an ultra-rare disorder mitochondrial disorder that causes either an infantile-onset neurodevelopmental and epilepsy syndrome or child or adolescent onset progressive spastic paraplegia with poor prognosis. Currently there is no cure, but our preclinical data shows promise in 4-hydroxymandelate (4- HMA) to rescue and reverse neurodegeneration in mice models, suggesting that this is a treatable disorder. This proposal aims to establish biomarkers and fit-for-purpose clinical outcome measures for a natural history study in HPDL deficiency syndromes.